Exercise effects on neural circuits for CVD risk

ABSTRACT
Project 3 (Kirk Erickson, PL)
Exercise effects on neural circuits for CVD risk
The mechanisms by which physical activity (PA) may reduce CVD risk remain unclear. Multiple lines of
evidence, however, show that PA – particularly aerobic exercise – exerts beneficial effects on brain health and
brain plasticity. Critically, the brain areas reliably affected by exercise are visceral control areas under study in
Projects (Ps) 1 and 2. These areas regulate aspects of peripheral autonomic, neuroendocrine, and immune
physiology that are involved in conferring CVD risk and favorably affected by exercise. Accordingly, we propose
to integrate historically separate lines of work on (1) exercise and CVD risk, (2) exercise and brain plasticity,
and (3) exercise and stress, affect, and physiological control. To this end, we propose a 12-month intervention
in which 150 midlife and inactive adults will be randomized to (1) 150 min/wk of moderate exercise (e.g., brisk
walking; N=75) or (2) a light stretching control group with similar health instruction and social interaction as
the treatment group (N=75). We will collect neuroimaging measures integral to Ps 1-2: behaviorally-evoked
neural activity, cerebral perfusion and functional connectivity, white matter integrity, and gray matter
morphology at 3 waves (baseline, 6-months, 12-months). Moreover, we use ambulatory CV monitoring and
ecological momentary assessment (EMA) methods for the first time to test whether exercise impacts daily life
stress physiology and affect, and whether these effects are partly explained by changes to visceral control areas.
Our design allows us to test several hypotheses by the following Aims: Aim 1: To determine the neurobiology
of exercise and biological CVD risk factors: (1A) Body-to-Brain hypothesis: Exercise-induced changes in
peripheral markers of CVD risk (e.g., insulin resistance, cardiorespiratory fitness, peripheral vascular function)
will precede and partly explain (statistically mediate) some of the exercise-induced changes in functional and
structural features of areas defining visceral control circuits. (1B) Brain-to-Body hypothesis: Exercise-induced
changes in functional and structural features of areas defining visceral control circuits precede and partly
explain (statistically mediate) consequent changes in autonomic and neuroendocrine mediators of CVD risk
that are under neural regulation, including baroreflex sensitivity, heart rate variability, and glucocorticoid
control. Aim 2: To determine the neurobiology of exercise and stress- and affect-related CVD risk factors: (2A)
Stress-related parameters of CVD risk: Exercise will induce changes in visceral control areas engaged by an
fMRI stress battery, and these changes will partly explain exercise-induced reductions in cardiovascular stress
reactivity in daily life (synergy with P's 1 & 2). (2B) Affect-related parameters of CVD risk: Exercise will induce
changes in visceral control areas engaged by an fMRI emotion processing and regulation paradigm in synergy
with P1, and these changes will partly explain exercise-induced improvements in affect measured in daily life
by EMA and by conventional self-report instruments in synergy with P2. The public health significance of this
Project is that it is designed to more precisely define and refine neurobiological targets to reduce CVD risk.

Public health relevance
PROJECT NARRATIVE Project 3 Exercise effects on neural circuits for CVD risk In this project, we propose a 12-month exercise intervention in 150 midlife adults. Our aims are to elucidate the mechanisms of exercise effects on CVD risk mediators, CVD risk markers, and brain plasticity. We also aim to test whether exercise-related changes in brain plasticity account for exercise-induced changes in stress- and affect-related parameters of CVD risk.